Immunological Analysis of Brain Cancer

This research project was newly established in April 2019 when I was hired as a tenure track investigator. I moved into the laboratory space in June and been actively hiring members of the lab and setting up the laboratory. In order to start in vivo experiments, the animal study protocol was submitted and mouse brain tumor cell lines to establish syngeneic models were obtained. At the time of this report, I am waiting on approval of the animal study protocol to be able to start in vivo experiments.